Dynamical maintenance of left-right symmetry during vertebrate development

Project Summary
Broad Objective: Maintaining anatomical symmetry in vertebrates is essential for proper
physiological function, and loss of symmetry in ribs and vertebrae can lead to serious conditions
such as scoliosis and impairments of appropriate breathing and posture. This project will
explore the developmental emergence of left-right symmetry, combining biological experiments
on wild-type mice and a model of early loss of symmetry with mathematical models of gene
expression and molecule distributions. Through these studies, the project will provide new
important insight into the determinants of body (a)symmetry.
Specific Aims and Research Design: The somites are the embryonic structures giving rise to
the vertebrae and rib cage. They are formed at early phases of embryonic development and
emerge progressively in pairs of paraxial mesoderm blocks on both sides of the midline in a
highly symmetric manner. The symmetry of the somites is actively maintained through
mechanisms controlled by retinoic acid (RA) signaling. Indeed, animals deficient in RA exhibit
an asymmetric somite formation. This proposal will investigate this RA-mediated symmetry
maintenance mechanisms by combining experiments on RA-deficient mice with mathematical
models of somitogenesis.
In Aim 1, to investigate the dynamical mechanism of somite formation in wild-type and RA-
deficient embryos, we will characterize finely the somite formation timing, period, and positions
in mouse embryos through live imaging techniques coupled with and topological data analysis.
In Aim 2, to study the genetic mechanism involved in the segmentation clock, which controls the
spatio-temporal formation of somites, the same live-imaging setup will be leveraged to extract
the dynamics of the segmentation clock in mouse embryos. This data will be used to develop
and specify a theoretical model of somitogenesis which will in turn allow exploring the
determinants of symmetry maintenance and its breakdown. To explore how asymmetry may
arise and be buffered by RA, Aim 3 proposes to study the origin of asymmetry in RA-deficient
mouse. It will rely on the development of computational fluid dynamics simulations to analyze
the global distribution of key signaling molecules as they are transported in fluids driven by cilia
movements. This will be coupled to reaction-diffusion systems and their dynamics will be
explored to investigate how RA-mediated mechanism can buffer any initial asymmetry in
molecular concentrations.

Public health relevance
Project Narrative Body symmetry is crucial for physiological posture and function. A prominent example of developmental failure in symmetry maintenance is fetal hemivertebrae, a rare congenital malformation that affects 5-10 in 10,000 births, resulting in spinal deformation such as scoliosis. This project will contribute to understanding the developmental origin of such body symmetry/asymmetry issues, and this improved understanding could lead, at term, to new medical treatments or preventive measures.